Preclinical In Vitro and In Vivo Agent Development Assays - Orientation Meeting

University of Alabama at Birmingham has been awarded as a prime contractor of RFP-N01-CN25001-26 entitled “Preclinical In Vitro and In Vivo Agent Development Assays.” They are scheduled to attend the orientation meeting that is scheduled on October 22, 2012.